Mechanisms of evolution at the host-pathogen interface

PROJECT SUMMARY
Pathogens and their hosts impose strong selective pressure on one another, leading to the rapid
evolution of host-pathogen molecular interactions. This process in turn can shape pathogen host range,
virulence, and the emergence or reemergence of infectious diseases in human populations. These
features also make host-pathogen interactions ideal systems to investigate fundamental evolutionary
processes including natural selection and the diversification of protein functions. While comparative and
population genomic datasets are now plentiful for many pathogens and animals, empirical studies are
required in order to test how specific genetic variants impact disease-related phenotypes. To meet this
need, our research group integrates evolutionary genetics with molecular approaches to
investigate the mechanisms and consequences of host-pathogen evolution. Our work focuses on
bacterial pathogens of humans, a leading cause of death worldwide and a growing source of
antimicrobial resistant infections. Using phylogenetic methods to identify rapidly-evolving genes in both
host and bacterial genomes, we develop and test hypotheses regarding the effects of genetic variation
using a combination of biochemistry, molecular genetics, cell biology, and laboratory microbiology. Our
group has leveraged this integrative framework over the last several years to initiate diverse projects
relating to bacterial colonization, nutrient acquisition, and immune evasion. Future studies performed
under this award will advance two general research areas. The first will investigate how rapid evolution
of animal and bacterial cell surface receptors impacts colonization and immune evasion. These studies
build from our recent findings illustrating how combinatorial processes of substitution, gene conversion,
and gene duplication contribute to bacterial-host receptor interactions. The second research area will
address how rapid evolution of host antimicrobial enzymes impacts activity against diverse bacterial
pathogens, as well as processes by which pathogens have evolved to evade these enzymes. Specific
projects under these research areas encompass diverse molecular interactions and multiple bacterial
pathogens, amenable to long-term investigation. Collectively this research program will uncover key
mechanisms and consequences of host-pathogen evolution to inform new strategies for combatting
bacterial infections.

Public health relevance
PROJECT NARRATIVE Genetic diversity among host and pathogen populations can have a major impact on infectious disease susceptibility. This research program will combine evolutionary genetics approaches with molecular experimentation to determine how genetic variation impacts host-pathogen interactions and the consequences for human bacterial infections.